DOUBLE BLIND RANDOMIZED PHASE III SURAMIN VS PLACEBO TREATMENT IN PROSTATE CANCER

The objective of this phase II study is to determine the effect of suramin on pain, performance status, PSA, disease response, quality of life & survival in patients with hormone-refractory prostate carcinoma & to evaluate the safety of suramin. Suramin is a polysulfonated napthylurea developed in the 1920's as a treatment for trypanosomiasis in Africa and onchocciasis. It has received attention more recently as a potential antineoplastic agent because of its ability to bind to a number of peptide growth factors.